Targeting the functions of the gonococcal Type IV pilus

PROJECT SUMMARY
Neisseria gonorrhoeae (Gc) is the sole causative agent of the sexually transmitted infection,
gonorrhea. The rapid rise in antibiotic resistance and a recent sharp increase in reported cases
in the U.S. have made this organism a target for the CDC, WHO, and NIH. This proposal will
focus on the N. gonorrhoeae Type IV pilus (T4p), an essential colonization and virulence factor.
We will investigate three novel aspects of Gc T4p biology that result from our ongoing studies.
We have identified three small molecules that inhibit N. gonorrhoeae T4p elaboration. These
chemicals inhibit the M23 class Mgp protease that targets Gc peptidoglycan (PG) to destabilize
T4p elaboration. One also has N. gonorrhoeae toxicity. We will determine whether related
compounds have similar inhibitory activity, how the compounds interact with Mpg, and how Mpg
interacts with PG. We have discovered a novel T4p biogenesis factor we named TfpC. We will
determine how TfpC alters T4p elaboration through genetic, biochemical, and physiology
studies. Finally, we have shown that T4p elaboration makes N. gonorrhoeae more resistant to
neutrophil-killing effectors. We have discovered that HpaC, a predicted FAD-dependent
monooxygenase, differentially alters N. gonorrhoeae sensitivity to oxidative and nonoxidative
killing in a pilus-dependent manner. We will determine whether HpaC does express FAD-
dependent monooxygenase activity and interrogate the metabolic pathways HpaC and the pilus
alter to alter sensitivity to PMN antimicrobial agents. These studies will strongly impact our
understanding of N. gonorrhoeae physiology, pathogenicity, and T4p pilus biology.

Public health relevance
PROJECT NARRATIVE Gonorrhea remains a significant public health issue that shows increasing rates and alarming antibiotic resistance. This work will investigate new compounds that inhibit the Neisseria gonorrhoeae pilus and study how two novel factors inhibit the pilus.